Psychosocial Predictors of Health Behaviors and Outcomes in Patients with Human Papillomavirus (HPV) Positive Head and Neck Cancer

PROJECT SUMMARY/ABSTRACT
Human Papillomavirus (HPV) related head and neck cancer (HNC) has increased in incidence by nearly 225%
since the 1980s and is expected to rise over the next forty years. Patients with HPV positive HNC typically
have lower rates of substance use and a more favorable prognosis than HPV negative HNC. Nevertheless,
patients with HPV positive HNC often experience significant side effects from extensive treatment regiments
and psychosocial distress secondary to facial disfigurement, symptom burden, and concerns about prognosis.
It remains unclear how this distress may contribute to health behaviors that have a direct bearing on relapse,
morbidity, and mortality in individuals with HNC. Despite the lower rates of behavioral risk factors associated
with HPV negative HNC (e.g., tobacco and alcohol use), patients with HPV positive HNC who engage in these
risk factors (≥ 50% of patients) are at an increased risk for recurrence or secondary malignancy. Among cancer
survivors generally, including HPV negative HNC, psychosocial distress (i.e., anxiety, depression, and fear of
cancer recurrence) has been associated with higher rates of tobacco and alcohol use. However, this
relationship has been understudied in the context of HPV positive HNC. This study involves a secondary
analysis of the Head and Neck 5000 study, a large longitudinal clinical cohort of HNC patients in the United
Kingdom. Through the parent study, patients with HNC were recruited shortly after diagnosis and prior to
cancer treatment, provided blood samples at baseline for HPV status, and completed self-report surveys at
baseline (diagnosis), 4-months, 12-months, and 5-years post-diagnosis. The current study aims to 1) evaluate
the trajectories of psychosocial variables (i.e., psychological distress, fear of cancer recurrence, and physical
symptom burden) in patients with HPV positive HNC from diagnosis to one year following diagnosis, 2)
examine the relationship between psychosocial variables and change in tobacco and alcohol use in patients
with HPV positive HNC during the first year after diagnosis, and 3) assess the role of health behavior change
on 5-year health outcomes (recurrence-free survival). This study will be the first to examine psychosocial
variables in association to health behavior change and long-term health outcomes in a large longitudinal
clinical cohort of patients with HPV positive HNC. Results will inform the need for resources in clinical care and
contribute to psychosocial and behavioral intervention development for patients with HPV positive HNC. This
Fellowship will provide the applicant with the training needed to launch an independent and productive
research program examining the psychosocial and behavioral processes affecting the quality of life of patients
with cancer. The proposed research and training plan will fill gaps in her discipline-specific knowledge in health
psychology, head and neck oncology, and HPV-infection. As well as enhance her skills in longitudinal
quantitative analysis and prepare her for a career as an independent investigator in academia.

Public health relevance
PROJECT NARRATIVE Human Papillomavirus (HPV) has emerged as a leading factor in the development of head and neck cancer (HNC); despite the more favorable prognosis of HPV positive HNC, patients may experience distinct patterns of psychological distress that contribute to health behaviors (i.e., tobacco and alcohol use) and have a direct bearing on relapse, morbidity, and mortality. However, the lack of knowledge of this relationship in the context of HPV positive HNC is a critical barrier to patient care and psychosocial intervention development. In support of the NCI’s mission of helping people with cancer live longer and healthier lives, results from this study will develop an understanding of the unique psychosocial needs of patients with HPV positive HNC and the association to health behaviors and long-term health outcomes.